The role of lung capillary endothelial cells in NFkB-directed alveolarization

PROJECT SUMMARY
Preterm birth affects 10% of pregnancies, with 40% of survivors developing bronchopulmonary dysplasia
(BPD), a chronic lung disease marked by dysmorphic vascular growth and alveolar simplification. Despite
advances in neonatal care, BPD incidence has not improved, and no therapies reverse its pathology. My long-
term goal is to define critical mechanisms of lung intercellular crosstalk during alveolarization to develop
therapies for BPD and other chronic lung diseases. Alveolarization is a key phase of lung development
involving synchronized endothelial and alveolar epithelial cell (AT) expansion to establish the gas exchange
surface. Endothelial cells (EC) influence lung development through angiogenesis and signaling to other cell
types. Our data show EC-specific deletion of IKKβ, an essential NFκB regulator, impairs alveolarization by
disrupting angiogenesis, reducing capillary EC and AT cell abundance, and altering cell-ECM interactions.
However, mechanisms governing NFκB/IKKβ activity in specific EC subpopulations remain unclear. The
central hypothesis of this proposal is that NFκB/IKKβ activity in capillary ECs promotes alveolarization through
cell-autonomous mechanisms that drive angiogenesis and cell-nonautonomous mechanisms that regulate AT
proliferation and alveolar niche organization. This will be tested in two aims: Aim 1: Identify cell-autonomous
mechanisms downstream of NFκB/IKKβ that promote angiogenesis in specific EC subtypes. Single-nucleus
RNA sequencing (snRNAseq) and CUT&RUN sequencing will define IKKβ-mediated proangiogenic gene
expression in EC subpopulations. Candidate gene validation in vitro (Hmbox1, Fzd4, Glp1r and others
determined from snRNAseq) will assess roles in EC proliferation and survival. Aim 2: Determine whether
endothelial IKKβ promotes AT proliferation and ECM organization via cell-nonautonomous mechanisms. We
will perform EdU proliferation assays, primary co-culture systems, and advanced imaging (transmission
electron microscopy and confocal-generated 3D renderings from thick sections) to assess the impact of EC-
IKKβ deletion on AT dynamics and alveolar niche architecture. Target genes among AT and identfied in Aim 1
will also be validated We will use the endothelial-IKKβ deletion mouse model we generated for in vitro and in
vivo outcomes. These studies will provide novel insights into the role of EC subtypes and NFκB signaling in
alveolarization and inform therapeutic strategies for BPD and other pulmonary diseases. Completion of this
project will also equip me with the expertise to conduct rigorous, independent research on lung vascular and
epithelial biology, and foster a career studying intercellular and ECM interactions within the alveolar niche.

Public health relevance
PROJECT NARRATIVE Nearly half of preterm infants develop bronchopulmonary dysplasia (BPD). Chronic lung diseases, like BPD, resulting from irreversible pathological changes to vasculature-epithelial interactions are top causes of death, without adequate therapies to reverse changes and reduce morbidity/mortality. Completion of this proposed research will elucidate molecular mechanisms governing developmental vascular-epithelial interactions to illuminate putative therapeutic targets that can reduce morbidity/mortality in chronic lung diseases like BPD.